Administrative Core

Summary - Administrative Core The proposed Center will feature an administrative core. This administrative core will take advantage of the extensive experience of the administrative staff of the Institute for NanoBioTechnology, where the Center will be housed, and experience drawn from our previous PSOC to coordinate the research, outreach, and dissemination programs of the Center. Therefore, we have already identified the members of the administrative staff of the Center. This administrative staff has extensive experience in the redaction of annual progress reports, organizing site visits, creating press releases and newsletters for outreach activities, organizing multidisciplinary symposia, annual retreat, and workshops which will take place during annual PSOC retreats and symposia; and managing research grant accounts (including pilot grants and transnetwork grants) and semi-annual reports to the NCI.